Arkansas Department of Health's Wholesale/Manufactured Foods Maintenance for State Manufactured Food Programs and Special Project

Arkansas Department of Health's Wholesale/Manufactured Foods
Maintenance for State Manufactured Food Programs and Special
Project
Project Summary
Currently the Arkansas Department of Health's (ADH)
Wholesale/Manufactured Foods Program (WMFP) in the Food Protection
Section of the Environmental Health Branch has been operational and
functioning since 2013. Previous to 2013, inspections of manufactured food
firms conducted by Arkansas Department of Health staff were conducted
on two-hundred firms listed on the Food & Drug Administration (FDA)
contract for the year. This project proposal will ensure continued
development and maintenance for the Wholesale/Manufactured Foods
Program
The Cooperative Agreement requested would continue to be used to
support our manufactured foods inspection program efforts for the state of
Arkansas so that our program progress to continues to meet full
conformance with the MFRPS; maintain support for our electronic
inspection program and ensure continuation of our participation with the
National Food Safety Data Exchange.
The ADH mission is to protect and improve the health and well-being of all
Arkansans. Building an IFSS and establishing a mutual reliance with
federal and state partners will support the ADH mission. With continued
FDA support, the Arkansas WMFP can continue to improve food safety
within Arkansas and prepare for unexpected food incidents that could
potentially extend beyond stateliness in the future. If the award is not
approved for the systems and resources requested, the ADH would not be
able to continue to fund a Wholesale/Manufactured foods program.

Public health relevance
Arkansas Department of Health's Wholesale/Manufactured Foods Maintenance for State Manufactured Foods Program & Special Project Project Narrative The Arkansas Department of Health's (ADH) Wholesale/Manufactured Foods Program (WMFP) is submitting application for three years maintenance support of the Manufactured Food Regulatory Program Standards (MFRPS) and Special Project. The total amount of requested for the cooperative agreement is $697,988.23 dollars.